Thrombospondin 4 regulates adaptive ER stress responseRenewal - Resubmission - 1

Abstract
Similar to skeletal muscle myofibers, cardiomyocytes in the heart appear to be particularly susceptible to
membrane instability and rupture during disease, in part because of their contractile status that produces
ongoing mechanical deformation. Mutations in genes that disrupt or weaken the membrane anchoring
proteins of the dystrophin-glycoprotein complex (DGC) or the integrin adhesion network causes a wide range
of muscular dystrophies that also cause cardiomyopathy. We have shown that the thrombospondin gene
family (Thbs1-5) plays a critical role in membrane stability through both effects on the ER stress response
and secretory pathways, as well as controlling the integrin complexes present on the sarcolemma. In our
previous cycle of funding, we showed that overexpression of Thbs3 has a remarkable effect of reducing
sarcolemma stability in heart (opposite of Thbs4) by removing large arrays of integrin heterodimers from the
adhesion complexes, while Thbs3 KO mice have enhanced integrin membrane levels and are protected
from insults that would otherwise cause cardiomyopathy, like overexpression of Thbs4 that also increases
membrane stability by increasing membrane attachment protein complexes in the sarcolemma. However,
several critical mechanistic questions remain to be addressed in attempting to translate our findings into
therapeutic approaches. Here we propose the unifying hypothesis that the cardiac expressed Thbs proteins
primarily function from within the secretory pathway in mediating the stability, or recycling of membrane
attachment complexes, which has profound effects on sarcolemmal stability and healing dynamics within the
heart with both acute injury and chronic disease, which will suggest potential novel gene therapeutic
ventures for cardiomyopathy in heart failure or with muscular dystrophy. To interrogate this hypothesis, we
propose the following 2 Specific Aims: 1) Mechanistically define how Thbs3 and Thbs4 antithetically regulate
sarcolemmal stability through integrin processing for gene therapy application in cardiomyopathy and
muscular dystrophy. 2) Examine the molecular mechanism of dilated cardiomyopathy in a mouse model for
the Human THBS4 D717N variant. The goal will be to better understand human heart disease through the
Thbs gene family and how it regulates membrane stability and adhesion complex activity. Translational
implications are that a better understanding of these molecular mechanisms will suggest why humans with
mutations in Thbs4 show dilated cardiomyopathy and will suggest modified versions of Thbs4 to be used in
gene therapy approaches to treat muscular dystrophy, as well as a wide array of heart diseases in which the
membrane is weaker.

Public health relevance
Narrative The endoplasmic reticulum (ER) stress response appears is a universal feature of all cardiomyopathies as well as healing after cardiac injury or disease initiation. Here we have identified a novel function for thrombospondin3 (Thbs3) and Thbs4 as intracellular regulators of the ER pathway shuttling of membrane attachment complexes, such as the integrins and dystrophin-glycoprotein complex (DGC), which impacts the stability of the plasma membrane in heart and skeletal muscle. Understanding the mechanisms whereby the Thbs proteins regulate cellular attachment complexes in the plasma membrane has profound medical relevance as many forms of heart disease are associated with altered membrane strength and cellular connection to the extracellular matrix.